Validation of blocking TSP4/Cava2d1 interaction as a new target for neuropathic pain

Supplement Project Abstract Statement It is included with the supplement research plan

Public health relevance
Supplement Project Narrative Statement The original Project Narrative has not changed as a result of the proposed supplement activities.